PHASE I TRIAL OF FP-21399 IN PATIENTS WITH HIV INFECTION

To assess the toxicity profile and pharmacokinetic parameters and determine the maximum tolerated dose of FP-21399 in patients with HIV infection.